A Longitudinal Brain and Behavior Study of Autism From Infancy Through Adolescence

Project Summary
This application is a competing continuation of an Autism Centers of Excellence (ACE) Network entitled, “A
Longitudinal Brain and Behavior Study of Autism from Infancy through Adolescence”. Prior funding supported a
prospective, longitudinal study that has collected high quality brain imaging and behavior assessments in
children at high- and low- familial risk (HR, LR) for autism spectrum disorder (ASD), starting in infancy, and at
various points at 3-6-9-12-15-24-36 months to 7-11 years of age. Key findings from this network have revealed
that: (1) early brain features of ASD are detectable by 6 months of age, well before diagnosis is possible; (2)
ASD-specific brain and behavior features change substantially throughout early childhood, as ASD emerges;
and (3) brain features in the first year of life are associated with later ASD behaviors and accurately predict ASD
diagnosis in individuals at 24 months of age. The overarching goal of this ACE Network proposal is to extend
into adolescence the follow-up of a prospective cohort of 400 subjects (300 HR; 100 LR) with detailed brain and
behavior assessment between 13-16 years of age. Adolescence is a time of substantial challenges to autistic
individuals. It is the time of peak onset of psychiatric disorders, rates of which are considerably higher in ASD
than in the general population, with particular vulnerabilities in ASD females. Adolescence sets the stage for
transition to early adulthood, a time when decline in daily living skills and worsening outcomes in ASD are
commonly reported. In this application we therefore propose to: (Aim 1) characterize brain and brain-behavior
trajectories in those with ASD, from infancy through adolescence, to gain insights into developmental
mechanisms that inform the timing and targets of intervention; (Aim 2) identify infant-to-school-age brain and
behavior features in those at elevated ASD familial risk, that predict clinically-relevant outcomes in adolescence
and, (3) define the expression of familial ASD risk in adolescent females, identify early childhood markers of
adolescent clinical impairment and, characterize patterns of infant-to-adolescent brain development, in
adolescent females at high familial risk for ASD. This study would be the first prospective examination of brain
and behavior features associated with ASD risk, in the same individuals, from infancy through adolescence. It
has the potential to: (1) inform about the nature and timing of underlying mechanisms and targets of intervention;
(2) elucidate childhood brain and behavior features that predict individual-level, adolescent dysfunction, related
to familial ASD risk; and (3) to provide new insights regarding the expression of ASD risk in adolescent females,
their identification earlier in childhood and associated patterns of brain development. This proposal addresses
“areas of interest” specified in the ACE RFA, including: (1) a focus on under-studied subgroups e.g., individuals
with ASD and co-occurring psychiatric conditions (Aim 1 and 2) and females with ASD (Aim 3); and (2) biological
mechanisms related to family-genetic and environmental interactions (Aim 1 and 2).

Public health relevance
Project Narrative This ACE Network proposal, entitled “A Longitudinal Brain and Behavior Study of Autism from Infancy through Adolescence”, aims to examine 400 children (300 infants at high familial risk and 100 infants at low familial risk for autism spectrum disorder (ASD)), who have been previously examined at multiple time points from infancy through school-age, using detailed brain imaging and behavior assessments, and who are now proposed for re- assessment in adolescence. The main goals of this proposal are to characterize brain and brain-behavior relationships in ASD, from infancy through adolescence; identify infant-to-school-age brain and behavior features that predict clinically-relevant outcomes in adolescence that are associated with familial risk for ASD; and to employ a novel approach to define the expression of familial ASD risk in adolescent females that will have more relevance for biological studies than current definitions, identify early childhood markers of clinical impairment associated with ASD risk, in adolescent females (who are often not detected earlier in childhood); and, characterize infant-to-adolescent brain development in ASD females. This study will facilitate the development of early childhood approaches to identifying poor outcomes in adolescents at risk for ASD and provide insight into the timing and nature of early interventions for ASD and related conditions.